Dynamic Biological Hydrogels to Modulate Cardiac Remodeling Following Myocardial Infarction

Summary: Heart disease is the leading cause of death in the United States and there are currently over 5 million
people in the U.S. affected by heart failure (HF). One potential therapeutic that is currently undergoing Phase I
clinical trials is the injection of solubilized cardiac extracellular matrix (cECM) derived from adult porcine left
ventricle. Healthy porcine cECM mimics the native binding sites available to cells and has been shown to promote
functional repair in a pre-clinical model of MI, but cECM alone is limited in terms of the ability to mechanically
stabilize the infarct during remodeling as the gels formed by cECM are softer than normal myocardium (~3-7
kPa). This is important because hydrogels with a higher stiffness than native myocardium injected into the infarct
have been shown to reduce pathological remodeling, indicating that modulation of stiffness may be an important
tool to regulating healing response. The protein composition of the ECM also has a profound effect on cells and
we, and others, have demonstrated significant changes to the cardiac ECM protein composition in normal
development and in disease, which modulates cardiac cell proliferation, progenitor/stem cell differentiation, cell
traction force against the ECM and paracrine signaling from stem cells in the infarct environment, among other
effects. In particular, our lab has demonstrated the potential utility of ECM derived from younger developmental
ages in promoting a more regenerative healing response, and preliminary data indicates that this also occurs in
the context of adult injury as well. As younger animals have the capability of regenerating their hearts to a greater
degree, a logical hypothesis is that this difference in regeneration potential is at least partially derived from the
remodeling of the ECM in which the cells reside at that point in development. We propose the development and
use of biomaterials that can dynamically change to mimic a more developmentally regenerative niche for cardiac
tissue repair. Our central hypothesis is that injectable, highly elastic silk-cECM composite hydrogels containing
fetal heart derived cECM will provide a means for mechanical stabilization of the infarcted ventricular wall while
promoting more favorable remodeling by cardiac cells, leading to improved repair and the minimization of
diastolic dysfunction. To assess this hypothesis, we will use combinations of silk-based crosslinked hydrogels
and a series of relevant chemical modifications to achieve physiologically relevant mechanical properties with a
range of dynamics. The samples will be characterized for their physicochemical properties and evaluated both
in vitro and in vivo. We will then assess the impact of the incorporation of young developmental age cECM to
our dynamic silk hydrogels on cardiac cells in vitro and cardiac remodeling in vivo. We hypothesize that optimized
silk-cECM based formulations will enhance diastolic heart function and reduce ventricular wall thinning following
injection 1-week post-MI. Weekly functional assessment (echo) and endpoint hemodynamic functional
assessment (PV loops) will be used to monitor cardiac function over an 8-week repair timeline in rats.

Public health relevance
Project Narrative: Heart disease is the leading cause of death in the United States and there are currently over 5 million people in the U.S. affected by heart failure (HF). Current treatments for preventing the progression to heart failure are only mildly successful. In this proposal we seek to develop a new biomaterial to prevent the progression to HF that mimics the tissue environment that occurs in younger hearts, where healing and regeneration are more successful.